Rutgers Biotechnology Training Program

PROJECT SUMMARY/ABSTRACT
The overall goal of the Rutgers Biotechnology Training Program (BTP) is to provide outstanding predoctoral
students with an integrated multidisciplinary educational and research training experience in biotechnology.
The specific aims are to 1) increase the number of well-trained PhDs able to conduct cutting-edge research in
biotechnology and related areas; 2) to increase the number of under-represented minorities receiving
biotechnology related degrees; and 3) to enhance the overall training experience by re-envisioning predoctoral
education through a diversified set of enrichment activities with appropriate reinforcement throughout the
training period. This comprehensive program builds on our ~35 years of prior experience and continuous
NIGMS support. Students in the program receive 1) broad training across biomedical disciplines, 2) the skills to
independently acquire the knowledge needed to advance their field, 3) the ability to think critically and
independently, and to identify important research questions that advance the boundaries in their areas of
study. The program provides 2 years of funding to meritorious students in their 1st or 2nd years, with the
contractual requirement that students participate in all program activities for their entire graduate careers. We
are requesting 12 slots from the NIH with the intention that trainees complete their dissertations in 4-6 years on
average and enter primarily research and research-related careers. The training experience involves a unifying
and multifaceted curriculum which includes: 1) specialized courses and experiential activities that provide the
student with critical perspectives of the field from multiple vantage points; 2) summer industrial internships; 3)
training in responsible conduct of research and rigor/reproducibility; 4) individualized mentoring, 5) an annual
symposium; and 6) a PhD dissertation research project in one of the laboratories of 38 participating faculty
mentors who are appointed in many different life science and engineering departments. We are requesting 12
NIH-funded predoctoral positions per year for 5 years. Rutgers has committed significant matching support,
stipend and tuition supplements, and other salary and administrative support. Industrial interaction is
exceedingly strong, with industrial investigators participating in teaching courses, presenting at the Annual BTP
Symposium, hosting summer interns, providing matching support, serving on thesis committees, and
occasionally hosting students for a part of their PhD dissertation work. The participating graduate programs
and related centers provide exceptional facilities for comprehensive biotechnology research and education.
Vigorous and extensive recruitment efforts are expended to attract students from under-represented groups,
and only students of exceptional abilities and motivation are admitted. Student progress is continuously
monitored through progress reports, individual development plans, and annual one-on-one meetings with the
program directors. These progress documents, as well as surveys of students’ progress during training and in
their careers after they leave the university are used to evaluate the effectiveness of the program.

Public health relevance
NARRATIVE The proposed training program produces highly trained graduates that apply the tools of science and engineering to significant research problems in biology and medicine. With their unique skills and perspectives, graduates of the program are well prepared to advance human health and welfare through original discoveries, and through the development of new drugs, materials, and devices for use in exploratory investigations, diagnosis, and therapy. These professionals will play a critical role in maintaining our country’s leading role in biotechnology on the world scene.